Leadership, Planning and Evaluation

PROJECT SUMMARY – LEADERSHIP, PLANNING AND EVALUATION
The Dan L Duncan Cancer Center (DLDCCC) has a committee structure that provides a robust framework
for evaluating activities in its research, clinical, education and outreach missions as well as reviewing
programs, disease working groups and shared resources. The Director, Kent Osborne has broad authority
across strategic planning and evaluation and engages senior leaders and external advisors to provide input and
refine his vision. The senior leadership including Dr Osborne, a Deputy Director and 11 Associate
Directors comprise the Executive Committee (EC) which is the key decision-making entity along with the
Program Leaders Committee which includes the EC as well as program leaders. A number of other
committees support specific areas such as Clinical Research, Shared Resources, Education and Community
outreach and report metrics to the EC as part of the evaluation process for all DLDCCC components. The
Director and the leadership team develop strategies to enhance the DLDCCC’s basic, translational,
clinical, and population science research efforts, monitor education and community outreach and
engagement efforts, and identify opportunities for collaborations and new research directions. Dr Osborne and
the senior leadership obtain additional advice from an Internal Advisory Committee that includes Department
Chairs and Center Directors at Baylor College of Medicine and an engaged External Advisory Committee
which meets annually and has provided valuable input in the last funding period. The DLDCCC has recently
completed an extensive strategic planning process, with input from all members which has resulted in new 5-year
strategic plan in 2016. This plan focuses on promoting high impact collaborative basic, translational, clinical and
population science research that serves our catchment area.